Project 4: Human Endometrial Programming for Successful Implantation

PROJECT SUMMARY/ABSTRACT
Events in early implantation are key to fertility and pregnancy success, and the uterine lining (endometrium)
plays a critical role in assuring acceptance and sustenance of the conceptus at the beginning and throughout
gestation. Essential for pregnancy establishment and maintenance is the progesterone (P4)-induced
differentiation (decidualization) of the endometrial stromal fibroblast (eSF) to the “decidualized” phenotype,
characterized by major genomic, transcriptomic, morphologic and functional transformations. We found that
human eSF derive from the endometrial mesenchymal stem cell (eMSC), and in women with endometriosis, an
inflammatory disorder associated with infertility, miscarriage and other poor pregnancy outcomes, eSF have an
abnormal response to P4 that is inherited from eMSC, compared to controls. We also found that steroid
hormones regulate the eSF DNA methylome and women with endometriosis have pre-existing eSF genome-
wide aberrant epigenetic marks associated with gene expression changes and that their eSF have a pro-
inflammatory phenotype likely acquired in the endometrial niche. Our overall hypothesis is that epigenetic
mechanisms regulate eMSC differentiation and the decidualization of their eSF progeny and that inflammation
in endometriosis alters these processes and compromises eSF function and the steroid hormone response
essential for successful implantation. We propose 3 specific aims: Aim 1: Test the hypothesis that genome-
wide epigenetic programming of eSF is inherited from its progenitor and changes in response to steroid
hormones and affects eSF functionality. Aim 2. Determine endometrial immune features of the inflammatory
milieu in endometriosis and their effects on eMSC lineage differentiation and eSF decidualization. Aim 3. Test
the hypothesis that endometriosis results in an aberrant eSF response to soluble signals from placental
cytotrophoblasts (CTB) important in implantation. We propose advanced molecular and epigenomic
approaches, functional studies to determine roles of candidate genes in decidualization, innovative CyTOF
technology to deeply phenotype specific immune populations in the endometrium, advanced computational
methods for data integration, and deep learning tools combined with high-throughput imaging to map changes
in cell morphology space onto transcriptome changes in epigenetically regulated cells. Understanding
mechanisms underlying eSF lineage specification from eMSC, eSF response to steroid hormones,
communication with the invasive CTB, and effects of inflammation on these processes is highly significant to
reproductive success and the health and well-being of those who conceive and their offspring. The expected
results are to derive an in-depth understanding of the role of P4-resistance and inflammation in endometriosis
that can also inform infertility and poor pregnancy outcomes in women with other inflammatory disorders. Also,
reprogramming eSF and eMSC could lead to novel therapies to maximize functionality of these cells in normal
implantation and endometrial homeostasis more broadly.

Public health relevance
PROJECT NARRATIVE This project proposes studies to understand the environment in human uterine endometrium preparing for embryo implantation normally and in the inflammatory disorder, endometriosis. Understanding normal and abnormal endometrial cell function and cross-talk between the endometrial stromal fibroblast and the placental cytotrophoblast is paramount, as these cells and their communications determine the success or failure of establishment, continuance, and outcomes of pregnancy, critical to human fertility and reproductive potential.